Long Term Genital Nerve Stimulation to Improve Urinary Continence

Neurogenic bladder dysfunction after neurologic disease or injury such as spinal cord injury (SCI) can lead
to bladder hyper-reflexia where the bladder reflexively contracts repeatedly at small bladder volumes. Bladder
hyper-reflexia can trigger autonomic dysreflexia, result in incontinence, urinary tract infections, renal damage
and decreased independence and quality of life. Our long-term goal is to develop and clinically implement a
“bladder pacemaker” able to restore bladder continence for veterans with SCI.
Electrical stimulation of the sensory genital nerves inhibits the spinal neural circuits involved in hyper-
reflexive bladder spasms. Genital nerve stimulation (GNS) has been used by multiple groups to inhibit reflexive
neurogenic bladder contractions during acute (1 visit) urodynamic testing. However, the effectiveness of
stimulation of sensory pathways can habituate or decrease with repetitive activation. We have recently
demonstrated that surface GNS inhibits reflexive bladder contractions and reduces incontinence in individuals
with SCI during one month of home use using a limited stimulation system. Veteran feedback from these
studies identified a number of stimulation system issues that negatively impacted activities of daily living and
prevented some subjects from participating in the study. Required improvements include elimination of wired
connections, a smaller device, expanded stimulation capabilities, and an improved user interface.
The purposes of this proposal are to 1) determine the effectiveness of sensory nerve stimulation to
chronically (≥1 year) reduce incontinence and improve quality of life for veterans with SCI and 2) produce an
effective take home GNS system that can be used by more individuals and used for multi-site studies. The
success of this study will be used to conduct a multi-site study of GNS and lead to clinical implementation.

Public health relevance
Bladder spasms after spinal cord injury (SCI) can result in incontinence, urinary tract infections, kidney damage, trigger dangerous increases in blood pressure and decrease independence and quality of life. 25% of all individuals with SCI in the US are veterans. Our long-term goal is to develop and provide a “bladder pacemaker” able to restore bladder continence for veterans with SCI. Electrical stimulation of sensory nerves can stop bladder spasms during a doctor visit. However, this approach has not been tested during long term home use. Veteran feedback from our initial testing identified a number of stimulator issues that must be addressed for them to use the system at home. This proposal will 1) determine how well sensory stimulation reduces incontinence and improves quality of life for veterans with SCI during ≥1 year of home use, and 2) produce an effective take home system that can be used by more veterans and other VAs.